Probabilistic deep learning models and integrated biological experiments for analyzing dynamic and heterogeneous microbiomes

Our microbiomes, or the collections of trillions of micro-organisms that live on and within us, are highly dynamic
and have been implicated in a variety of human diseases. Sophisticated computational approaches are critical
for analyzing increasing quantities and types of microbiome data, including time-series, assays for non-bacterial
components of the microbiome, and multiple measurement modalities such as metabolite and gene expression
levels. Another exciting recent trend in the field has been translational applications, particularly live bacterial
therapies for treating human diseases. In parallel, the field of machine learning has been advancing with deep
learning technologies that have dramatically improved applications such as speech and image recognition. My
lab develops novel machine learning methods and experimental approaches for understanding the microbiome,
with a particular focus on microbial dynamics and bacteriotherapies. In the past five years, we have developed
new computational methods and released open-source software tools for assessing the consistency of changes
in the microbiome induced by therapeutics, forecasting population dynamics of microbiomes, and predicting the
status (e.g., presence of disease) of the human host from changes in the microbiome over time. I have also led
experimental efforts to delineate the role of bacteriophages in microbiome dynamics and to develop gut
metabolite-based biomarker assays to predict recurrence of C. difficile infection. Additionally, with collaborators,
we have developed candidate bacteriotherapies for C. difficile infection and food allergies. My overall vision for
my lab in the next five years is to leverage deep learning technologies to advance the microbiome field beyond
finding associations in data, to accurately predicting the effects of perturbations on microbiota, elucidating
mechanisms through which the microbiota affects the host, and improving bacteriotherapies to enable their
success in the clinic. I plan to accomplish this by developing new deep learning models that address specific
challenges for the microbiome, including noisy/small datasets, highly heterogenous human microbiomes, the
need for direct interpretability of model outputs, complex multi-modal datasets, and constraints imposed by
biological principles. My plan is to directly couple computational models and biological experiments through
reinforcing cycles of predicting, testing predictions with new experiments, and improving models. Approaches I
will pursue include incorporating into deep learning models probability, embeddings of microbes and other
entities using rich information (such as gene content or chemical structure), decomposition of multi-modal data
into interpretable and interacting groups, and automated design of new biological experiments in gnotobiotic
mice that seek to maximize information for computational models and ultimately improve engraftment and
efficacy of candidate bacteriotherapies. An important objective will also be to make computational tools that my
lab develops widely available to the research community, through release of quality open-source software.

Public health relevance
Our microbiomes, or the collections of trillions of micro-organisms that live on and within us, play important roles in our health, and when disrupted, have been implicated in human diseases including infections, allergies, cancers, diabetes, liver, kidney, heart, and neurological disorders. Recently, new technologies are enabling exploration of our microbiomes in unprecedented detail, and exciting advances have been made in developing therapies that alter the microbiome with the objective of treating diseases. I propose to build new computational tools to analyze rich microbiome datasets as well as carry out integrated biological experiments, with the goals of both providing freely available tools to the research community for increasing fundamental knowledge of how our microbiomes affect us, and for purposes of accelerating development of therapies that target the microbiome for treatment of human diseases.